A pilot trial of the Individualized Placement and Support model in autistic adults in the community

ABSTRACT
Over half a million autistic young adults will graduate from high school over the next ten years. As they enter
early adulthood and no longer receive funded services through the education system, they will become
increasingly disengaged from expected adult roles including getting and staying employed. Based on current
statistics, about 40% of these adults will be placed in state-funded day programs or sheltered workshops
where they will not work in actual paid employment. Most of the remaining 60% will remain chronically
unemployed, underemployed or employed in non-competitive jobs that don’t match their skills or interests.
Although engaging in meaningful work is one of the most important determinants of mental health, physical
health, and quality of life in all adults the autism services field lacks an empirically validated supported
employment model that can be scaled up and financially sustained in community settings and that promotes
competitive integrated employment (CIE) as an endpoint. In this R34 application we address this urgent
problem by continuing and advancing our current pilot study funded by the California Department of
Developmental Services (DDS; Grant A22-334). In this pilot, we are implementing the Individualized Placement
and Support (IPS) model of supported employment – a person-centered model with a strong evidence base of
28 randomized clinical trials (RCTs). Thus far, using the core un-adapted IPS model, we have achieved CIE
rates of 41%. Notably, we have observed potentially mutable issues related to improving agency selection and
training. We also propose that increasing positive parent engagement, and helping consumers improve work-
related social cognition, may serve as mediators of intervention success and potentially improve model
outcomes. In Aim 1 of this R34 application, draw upon our experience in the DDS pilot, where we identified
challenges to agency selection and training, and conduct iterative focus groups with the DDS pilot consumers,
parents/carers, vocational support professionals (VSPs), employers and members of a community academic
partnership panel (C/APP) to investigate these and additional barriers and facilitators of IPS success. We will
then integrate this information to create a consumer support toolbox (CST) to be used to improve IPS model fit.
We also field test the CST used with IPS – together they are referred to as IPS-AUT-- in 5 consumers. In Aim
2, we conduct a 12-month Hybrid Type1 trial of IPS-AUT where we examine acceptability, feasibility and
preliminary effect sizes for employment outcomes as well as IPS fidelity. We hope to achieve at least 75%
acceptability and feasibility and to achieve at least 50% CIE. In Aim 3, we preliminarily investigate signals of
effect for proposed mediator (target) variables including parent/carer engagement and work-related social
cognition. The goal of this project is to prepare us to successfully compete for an adequately powered R01-
funded effectiveness trial of IPS-AUT in community settings. Our goal is to address the need to competitively
employ the large population of able autistic persons, and in so doing, to improve their mental health outcomes.

Public health relevance
PROJECT NARRATIVE Currently, a very large group of young autistic adults remains chronically unemployed, underemployed or employed in jobs that are not competitive and that don’t match their interests or skills. The goal of this application is to use stakeholder input to create a community support toolbox to be used together with Individualized Placement and Support (IPS) -- the most evidenced-based supported employment model for persons with neuropsychiatric disabilities -- for young adults with ASD ages 21-30 years; to conduct a randomized wait list controlled trial (RCT) of the combination IPS and the CST (IPS-AUT) to evaluate the feasibility, acceptability, and success of this new model; and to preliminarily investigate whether the model outcomes are associated with two variables—positive parent/carer engagement and consumer emotion regulation-- that could be tested as target mechanisms in a more adequately powered clinical trial.